Role of serum advanced glycation end-products in altering tendon properties with diabetes

PROJECT SUMMARY
Impaired tendon biomechanical function reduces mobility and quality of life for the majority of the ~30 million
Americans with diabetes, resulting in a substantial economic burden to these individuals and society. Any new
approach to enhancing tendon function in people with diabetes is hindered by a poor understanding of the
underlying etiology of impaired tendon biomechanical properties. Critically, the role that various serum factors
play in the development of tendon complications in individuals with diabetes remains unclear. Our
multidisciplinary research team hypothesizes that increased serum advanced glycation end-products (AGEs),
with subsequent activation of receptors for AGEs (RAGE), is a principal mechanism driving tendon
complications with diabetes. Specifically, activation of RAGE impairs tenocyte function resulting in loss of
collagen fibril organization and subsequent impairment of biomechanical function. AGEs accumulate in the
serum of patients with diabetes. Our preliminary cell culture work shows that treating tendon-derived cells with
AGEs, which cannot form collagen crosslinks, adversely affects critical aspects of tendon ECM maintenance.
We have also found that AGEs promote an environment favoring tendon ECM degradation. Utilizing human
subjects, we demonstrate that increasing serum AGE concentrations are associated with declining tendon
biomechanical properties (e.g., modulus). Serum AGEs can interact with RAGE to promote inflammation and
oxidative stress, but such a connection to changes in tendon ECM organization and biomechanical function
impairment has not been established. This project aims to 1) delineate the role of serum AGEs and activation
of RAGE in promoting tendon ECM disorganization and impairment of biomechanical properties and 2)
determine the relationship of serum AGEs to in vivo tendon biomechanical properties and in vivo indicators of
tendon collagen fibril organization. Filling these gaps will promote new approaches for improving tendon
function and reducing this challenging clinical condition's economic and social burden. Using a mouse model
with an inducible RAGE deletion and a model of type 2 diabetes, we will assess the effects of chronically
elevated serum AGEs on tendon ECM organization and biomechanical function and the involvement of RAGE
in this process. We will use novel ultrasound and magnetic resonance imaging (MRI) methods to determine the
relationships between serum AGE concentrations, in vivo tendon modulus, and MRI indicators of tendon ECM
organization. We expect this work to show that AGEs via RAGE signaling are a principal mechanism driving
changes in tendon ECM and subsequent reduction in biomechanical function in patients with diabetes.
Defining the role of serum AGEs and RAGE signaling in the development of the diabetic tendon phenotype will
provide an avenue to evaluate novel treatment approaches to reduce the impact of tendon complications in
patients with diabetes. Our proposal fits NIAMS's mission of developing treatment strategies for tendon-related
injuries. Our project addresses NIDDK’s mission of developing strategies to prevent and treat complications of
diabetes.

Public health relevance
NARRATIVE This project seeks to understand the role of serum advanced glycation end-products in the high frequency of tendon injury and impaired function in millions of Americans with diabetes. This critical project will use genetic mouse models and the study of people with diabetes to delineate the role of serum advanced glycation end- products in tendon injury and impaired function. With a long-term goal of developing new prevention and treatment strategies, this research will identify novel serum factors that drive tendon injury and impaired tendon function in the growing number of individuals with diabetes.